PHARMACOLOGIC MANIPULATION OF ENERGY MECHANISMS IN CARDIOMYOPATHY

The study examines the energy mechanics of cardiac muscle in patients with idiopathic dilated cardiomyopathy, both at rest and during inotropic stimulation. Patients will be treated for 6 months with metoprolol before undergoing a repeat investigation to assess the effects of long term beta blockade on myocardial efficiency.